Administrative Core

The administrative core, located at the Research Triangle Institute (RTI), will handle project management, coordination between investigators, and preparation of the IND. It will coordinate the support from NIDA. The administrative core will also assist the program in all administrative matters and will manage all routine administration of the program. It will ensure that proper records are kept, communication is maximized, and reports are prepared and handled efficiently. In addition, the administrative core will provide the administrative assistance required to facilitate interaction between the project leaders and the Principal Investigator, administer the financial aspect of the program, monitor and assist in the shipment of compounds to the projects, and coordinate the schedule for all meetings. In addition, the administrative core will provide plans for sharing research data.